GMKF competing renewal

Project Summary/Abstract
We propose to continue to provide data generation and processing activities that will enrich a
genomic data resource to propel pediatric disease research with this supplement proposal. Key
elements for success will be the provision of high quality genome sequence data on well-
phenotyped patients and their families; the collection and accessibility of data to the research
community in an intuitive manner; and the integration of genetic data with phenotypic
information in the context of this program and comparison to other large data resources. Our
center brings the domain expertise in high throughput data generation, processing and analysis,
and disease gene discovery required to meet the objectives of the Kids First program. We will
apply deep, high-quality whole genome sequencing and RNA sequencing data, among other
data types) on samples to be provided by investigators. We will be flexible to work closely and
accommodate the needs and interests of selected X01 Investigators. We will participate in the
evaluation of these data types and their overall impact on discovery and scientific output of the
program. A key feature of our center is our implementation of a robust analytical framework for
variant assessment and disease gene discovery, which builds on Broad investigators' world-
leading roles in statistical genetics, functional annotation, and clinical variant interpretation as
well as access to exome and genome data from hundreds of thousands of samples sequenced
at Broad. This has enabled us to build a systematic pipeline for gene discovery that will be
made freely available to the program. With data produced and processed in a consistent way,
we can offer seamless integration of data into our analytic framework. For many of the co-
morbidities targeted by the research community, confident discovery of causal genes will require
aggregation of cases across centers around the world. We will partner with the Data
Coordinating Center to enable the project to make the data available to investigators. With this,
we hope to support the Kids First research program as a whole and establish standards for data
sharing in clinical genomics, accelerating collaboration and facilitating robust gene discovery.

Public health relevance
Project Narrative The overall goal of this project is to generate high quality sequence data to help build a data resource for the pediatric research community. This resource will help researchers understand the underlying mechanisms of disease, leading to more refined diagnostic capabilities and ultimately more targeted therapies or interventions.